Tracing the Evolution of Chronic Lymphocytic Leukemia to Richter's Syndrome: Defining Transformation

Project Summary / Abstract
Recent advances have transformed the treatment landscape of chronic lymphocytic leukemia (CLL) and
improved patient outcomes. However, the transformation of CLL to Richter’s syndrome (RS) remains a major
barrier to disease control and limits survival. In CLL, genomic studies have advanced understanding of the driving
molecular events and biological pathways that underlie CLL development, progression and therapeutic
resistance, and enabled advances in clinical prognostication and tailored therapeutic approaches. In contrast to
CLL, the genetic basis of RS remains largely uncharacterized. Over the last few years, an analytic framework
was designed to overcome obstacles in the analysis of RS samples, including accounting for admixed CLL and
RS DNA and detecting copy number changes from archival tissue. As a result, pipelines have been established
to identify the CLL and RS clones and trace the evolution of CLL to RS. Using this approach, analysis of 40 RS
patient samples has been completed, leading to the identification of novel RS drivers, including disruption of
genes encoding epigenetic modifiers. Based on this preliminary data, Dr. Parry hypothesizes that recurrent
genetic and epigenetic driver events underlie the transition of CLL to RS and that the identification of
RS drivers will advance understanding of the biological pathways that drive transformation. To test this
hypothesis, she seeks to define the genetic drivers of RS through the comprehensive characterization of ~150
RS cases using whole exome sequencing and trace the evolution of CLL to RS (Aim 1). In Aim 2, she will identify
the epigenetic drivers of RS and examine how the transcriptome changes upon transformation to RS. In Aim 3,
she will examine the functional impact of recurrent RS drivers to yield insights into the cellular changes of
transformation. This research will provide a molecular definition of RS and identify biological mechanisms of
transformation, and thus, is a crucial step towards the goal of improving outcomes for patients with RS. Dr. Parry
has outlined a detailed five-year career development plan to meet her goal of becoming an independent
investigator focused on the biology and genetics of transformed lymphoma. In order to achieve this goal, she
has formed an Advisory Committee of mentors in cancer genetics, lymphoma biology and functional genomics
to provide her with detailed scientific and career mentorship. Additionally, she has formed collaborative
relationships with internationally recognized experts in computational biology, genomics, epigenetics, statistics
and CLL biology to provide her with project guidance, experimental input and training. The Dana-Farber Cancer
Institute is an ideal environment for Dr. Parry to achieve her career goals and execute her scientific plan, given
the world-renowned research community and strong focus on training the next-generation of independent
physician-scientists. Dr. Parry will have all the necessary resources to complete her proposed project and
achieve her goal of becoming an independent laboratory-based translational investigator.

Public health relevance
Project Narrative Richter’s syndrome (RS) is an aggressive malignancy of B cells that arises in a subset of patients with the otherwise typically indolent chronic lymphocytic leukemia (CLL), and dramatically limits survival in CLL patients. Despite advances in tumor sequencing techniques and analytic tools, the genetic basis of RS remains largely uncharacterized. The objective of the proposed studies is to identify and trace the origins of RS arising from CLL and define its molecular features in order to gain a deeper understanding of the subtypes of RS—which is anticipated to improve both the diagnosis and therapy of RS.